Constructing a Clinical Gulf War Illness (GWI) Case Definition Using Natural Language Processing and Advanced Machine Learning Algorithms

The overarching goal of this application is to develop a case definition of Gulf War Illness (GWI) for
application in the Veterans Health Administration (VA) electronic medical record (EMR) based on
advanced data science techniques. Background: Veterans from the Gulf War (GW, 1990–1991) continue to
experience medical issues, notably GWI. This ailment affects 15 to 45% of the 693,826 deployed Americans
and is attributed to toxic exposures encountered during the war. Common symptoms of GWI include chronic
fatigue, pain, respiratory issues, gastrointestinal problems, skin conditions, and neurological disturbances. The
Institute of Medicine recommended two definitions for research: Kansas and Centers for Disease Control and
Prevention (CDC) Chronic Multi-symptom Illness definition. There isn't a case definition for GWI that has been
universally accepted for clinical use because the illness presents differently in different individuals, the etiology
and pathophysiology are unclear, and there is no biomarker. Significance: The data collection for previous
attempts to develop a case definition were based on prospectively elicited self-reported symptoms only; the
rich information available in the EMR was not incorporated
. Consequently, the definitions were created without
the full range relevant information about the individuals’ health and bias or inter-individual variability in the self-
reported symptom presence and severity affects the validity of the case definition. In this application, we will
overcome these limitations by utilizing the full breadth of EMR (e.g., diagnosis and procedure codes, lab,
medications, and free-form text). Innovation: Our study encompasses several highly novel techniques,
including the development of NLP algorithms to extract signs and symptoms of interest from free-form text in
the EMR. The NLP algorithm will utilize conventional named entity recognition approaches and transformer-
based models. Additionally, we propose to use Theory of Belief to combine the EMR-based machine learning
(ML) models and NLP models. Aim1- Case definition by ML on EMR structured data, (ML-EMR): Develop
and validate a case definition for GWI utilizing structured data that can be applied in the VA EMR. Aim2- Case
definition by NLP on unstructured data (ML-NLP): 2a. Create an innovative case definition of GWI using
NLP algorithms on unstructured data, i.e., free text from the EMR. 2b. Explore the possible implementation of
transformer-based large language model (LLM) on free-form texts of patients with GWI to improve case
definition using NLP. Aim3- Case definition by combining ML-EMR and ML-NLP: Develop a hybrid model
for the case definition of GWI using unstructured and structured data models. Methodology: for Aim 1, we will
apply supervised learning methods (e.g., random forest and logistic regression) to the variables to train,
validate and test the model. Variables will be constructed from diagnostic and procedure codes, lab results,
and vital signs. For Aim 2a, we will use Medical Concept Annotation Tool (MedCAT) to automatically recognize
and link concepts in free text to standard terminologies, such as unified medical language system (UMLS).
Then, we apply ML algorithms to identify veterans with GWI. For Aim 2b, we will benefit from pre-trained LLMs
by fine tuning them with the annotated free-form texts of veterans with GWI. For Aim 3, we use Theory of Belief
to combine the output of the two proposed Aims (Aim 1 & Aim 2) from structured data and unstructured data.
Additionally, we utilize the full list of variables from EMR and NLP. Then we apply “most important variable
selection process” and construct the classifier to discriminate the veterans with GWI from those without.
Deliverables: This study will produce a continuous score indicating the probability of GWI from 0 (very low) to
1 (very high) for every GW veteran who has used VHA services. It will also create an enhanced, highly
interpretable case definition representing continuity with existing symptom-based criteria for GWI, such as
Kansas and CDC. In practice, the score could be made visible to a clinician in the patient’s EMR, and the
clinician could then apply the enhanced, interpretable algorithm to make a clinical determination of GWI.

Public health relevance
Gulf War Illness (GWI) has a been a mystery for more than 30 years- too long! This proposal will simultaneously address two major reasons for the slow progress toward better understanding, identification, management and study of this condition. First, it will optimize the current research case definitions for use in clinical practice and, second, it will produce a clinically relevant probabilistic indicator of GWI that can be displayed in the Veterans Health Administration (VA) electronic medical record. A point-of-care indicator of GWI could prompt clinicians to perform an evidence-based evaluation of the patient in accordance with an existing VA/Department of Defense Clinical Practice Guideline. In addition, researchers can use the same indicator, enhanced by clinician evaluation, to identify potential participants for research studies to better understand the underlying pathophysiology of GWI, potential subgroups of GWI, and test interventions to alleviate the suffering of these veterans. The results of this proposal would be groundbreaking.